Host Microbe Core

ABSTRACT
The Host Microbe Core (HMC) will assist and support the research base, trainees, and pilot project
investigators by providing specimens, reagents, training, and services to define both the microbial and host
response determinants of CF diseases in organs and tissues prioritized by the NIDDK. This Core combines the
resources and expertise of specialists in CF basic and clinical microbiology, airway epithelial and immune cell
biology, pathology, and microscopy to provide an integrated network of services, reflecting an evolution in the
field of CF disease pathogenesis to concurrently investigate the host and pathogens. Core services available
to the UW CF P30 research base include:
1. Technical assistance and state-of-the-art facilities for histopathology, immunohistochemistry, in situ
hybridization and localization of host and microbial targets, and digital imaging
2. Quantitative digital pathology and whole slide digital repository for pancreata and lungs from people
with CF
3. Processing clinical, animal, and laboratory specimens for microbiome, proteome, metabolome, and
transcriptome analyses, and for specific targets
4. Microbial culturing of CF specimens in formats representative of CF mucosal conditions for phenotypic,
proteomic, genomic, and biochemical analyses
5. Access to strains of bacteria cultured from CF clinical fecal samples, including Escherichia coli and
Bacteroides spp.
6. Consultation and training in methods provided by the Core and experimental design
7. Interacting closely with the Clinical and Genomics cores to provide unified services for CF researchers